Enhancing Susceptibility of HIV Reservoirs to CTL Through a Discovery to Translational Approach

PROJECT SUMMARY/ABSTRACT
Although modern antiretroviral (ARV) therapies have dramatically improved the outlooks for people living with
HIV, they are unable to cure infection. For people with HIV a cure would represent freedom from many burdens,
including stigma, expensive medications, and inflammation-associated co-morbidities. A cure would also have
public health benefits, comprising a powerful tool to help end the HIV epidemic. Developing a cure for HIV
requires developing an understanding of how the virus persists for years and decades in people, even when new
rounds of cellular infection (replication) are blocked by ARVs, and despite the ongoing presence of antiviral
immune responses. The dominant paradigm has been that the virus hides in a latent state in infected cells and
is thus invisible to immune responses. Efforts to cure infection have therefore focused on therapeutically
reversing HIV latency to expose these cells to elimination but have thus far yielded disappointing results. This,
along with several converging lines of evidence, have led to more recent hypothesis that hiding from the immune
system may not be the only mechanism by which HIV persists – but rather that these rare populations of infected
cells may have been selected for those that possess cell-intrinsic resistance to killing by cytotoxic T-lymphocytes,
even when they express antigen and are seen. This parallels recent findings from ImmunoOncology where it
has now been well established that some immunogenic tumors undergo selection for cell-intrinsic resistance to
CTL. For this project, we have assembled a team comprising a pioneer in establishing mechanisms of CTL
resistance in tumors, and two HIV experts who have advanced the idea of CTL resistance in this setting through
a series of ex vivo studies. By merging these areas of expertise, we Aim to comprehensively describe
mechanisms of CTL resistance in HIV-infected primary CD4+ T-cells and to discern which of these are at play in
real HIV reservoir cells from people with HIV. We will build from these results to select therapeutic targets and
identify combination approaches that integrate these with HIV-specific CTL and latency reversal strategies to
achieve specific elimination of HIV reservoir-harboring cells ex vivo. We will also leverage an innovative mouse
model to test whether engaging these therapeutic targets limits the seeding of HIV reservoirs in vivo. The results
of this project are thus expected to be: i) laying a broad foundation for understanding CTL resistance in the HIV
reservoir and ii) pre-clinical validation of multiple therapeutic targets with the potential to contribute to a cure for
HIV.

Public health relevance
PROJECT NARRATIVE Although HIV infection can be controlled by daily lifelong adherence to expensive antiretroviral ARV therapies, it cannot presently be cured. While infected cells often hide from the immune system in latency, converging evidence supports that these may also be seen by cytotoxic T-cells but are able to resist being killed. This proposal will address the unmet need of identifying and overcoming mechanisms of cell-intrinsic resistance to cytotoxic T-cells in persistent HIV reservoirs, with the aim of developing new therapeutic approaches to curing infection.